Cellular and Tissue Rejuvenation through Transcriptional Reprogramming

Summary
Organismal and cell rejuvenation are exciting new approaches to counteract aging, and recent breakthroughs
have brought them to the forefront of aging research. For examples, systemic factors in young blood was found
to rejuvenate various mouse tissues and brain function, and partial reprogramming with four stem cell
transcription factors (TFs) (Yamanaka factors) rejuvenate tissues and cells and extend the lifespan of mice.
These discoveries demonstrate that “young” and “old” can be described as different states, and the “old” state
can be reversed back into a “young” state through transcriptional reprogramming.
We hypothesized that there might exist many solutions to human cell rejuvenation through transcriptional
reprogramming, and some of the solutions may be safer and more potent than Yamanaka factors. In a recently
completed project supported by an NIH/NIA R21 grant, the Li lab developed a systematic approach to test this
hypothesis and to find the solutions. Using a human cell culture model of replicative aging employed by
Hayflick (continuously passaged human fibroblast cells), we developed a high throughput screen using
Perturb-seq to identify the potential rejuvenating TFs -- those that when over-expressed or repressed in old
cells, are capable of reprogramming the global gene expression program from the old state back to a younger
state. We identified four TFs/chromatin modifier (E2F3, EZH2, STAT3, ZFX) that when over-expressed or
repressed individually, are able to rejuvenate human fibroblast cells aged in vitro.
Here we propose to further test the rejuvenating effect of these four factors in human fibroblast cells aged in
vivo in their natural tissue environment, and in mouse liver. We will also develop new technologies to screen
for more potent rejuvenating TF combinations and test them in aged human fibroblast cells and in mouse liver.
If successful, this proposed study will identify TFs/TF combinations that can rejuvenate in vitro and in vivo aged
human fibroblast cells and mouse liver. This will set the stage for transgenic mouse study and translation to
human therapies. The methodologies developed in this proposal can be generalized to identify combinatorial
transcriptional programs that produce any desired cellular phenotypes, e.g., the reversion of the cellular state
from disease to normal in cell culture models of diseases.

Public health relevance
A fundamentally new approach to the treatment and prevention of age-related diseases is to target the root cause of aging. Under this new paradigm, rejuvenation of aging human tissues and organs represents a promising and exciting direction. Previously we identified 4 transcription factors that can rejuvenate human fibroblast cells aged in vitro through continuous passaging. This project proposes to test the rejuvenating effect of these factors in human fibroblast cells aged inside human body, and in mouse liver. New technologies will be developed to systematically identify combinations of transcription factors for rejuvenation. The proposed research will set a unique stage for discovering combinations of small molecule drugs for rejuvenation therapy.